USING MASS SPEC TO DETERMINE MOLECULAR IDENTITY OF TUMOR SPECIFIC ANTIGEN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Antibody phage display is a useful method of developing fully human monoclonal antibodies against both known and novel tumor antigens. We have obtained over 70 phage antibodies that specifically bind to and internalize within prostate cancer cells. Uncovering their molecular identities will lead to better understanding of cancer biology and better assessment of these molecules as targets for targeted immunotherapeutics. We propose to use immunoprecipitation and tandem mass spectrometry to obtain peptide sequences of antigens targeted by the antibodies.